Using Radiogenomics to Noninvasively Predict the Malignant Potential of Intraductal Papillary Mucinous Neoplasms of the Pancreas and Uncover Hidden Biology

PROJECT SUMMARY/ABSTRACT
Approximately 700,000 pancreatic cysts are incidentally detected by imaging each year. Up to 70% of these
radiologically-detected cysts are intraductal papillary mucinous neoplasms (IPMNs), bona fide precursor
lesions to pancreatic cancer, the only solid malignancy with a 5-year relative survival rate in the single digits.
Once detected, existing imaging modalities and molecular markers cannot reliably distinguish low/moderate
grade (benign) IPMNs that merit surveillance from high-grade/invasive (malignant) IPMNs that warrant surgical
resection, posing a great clinical challenge. Based on preliminary data generated by our group, we
hypothesize that unexplored categories of quantitative ‘radiomic’ features extracted from preoperative
computed tomography (CT) scans will have added diagnostic value in predicting malignant IPMN pathology,
compared to standard radiologic features. We further hypothesize that a liquid biopsy that measures
microRNAs circulating in blood plasma (a miRNA genomic classifier (MGC)) that we have developed may help
to further enhance diagnostic accuracy. The goals of this proposal are to 1) Evaluate the diagnostic
performance of novel radiomic CT features in predicting IPMN pathology, compared to standard radiologic
features, using data and specimens from a retrospective series (Aim 1a) and a prospective multi-institutional
series of IPMN cases (Aim 1b); 2) Generate prototype clinical decision-making models (nomograms) that take
into account radiomic data, the MGC, and other clinical characteristics (Aim 2); and 3) Evaluate the relationship
between radiomic features and biological processes that underlie IPMN tumor development and/or
progression. By leveraging interdisciplinary expertise and largely existing data unique to our institutions, our
long-term goal is to discover a combined quantitative imaging and biomarker approach that is noninvasive and
has added value in predicting IPMN pathology beyond that provided by standard radiologic characteristics.
This line of translational research has potential to foster clinically actionable information that could be used to
rapidly and cost-effectively personalize care for individuals with IPMNs and ultimately reduce the burden of
pancreatic cancer as a major health problem.

Public health relevance
PROJECT NARRATIVE Public Health Relevance: Intraductal papillary mucinous neoplasms (IPMNs) are cystic precursor lesions to pancreatic cancer incidentally-detected by imaging in up to 490,000 Americans each year. There is an unmet need to discover noninvasive approaches to differentiate ‘low-risk/benign’ IPMNs that can be monitored from ‘high-risk/malignant’ IPMNs that warrant surgery and its associated risks of morbidity and mortality. Our preliminary data suggest that quantitative ‘radiomic’ features and a blood-based ‘miRNA genomic classifier’ may improve diagnostic accuracy. In this proposal, we plan to 1) evaluate the value of radiomic features in predicting malignant versus benign IPMN pathology in retrospective and multi-institutional prospective cohorts, 2) build prototype clinical decision-making models that take into account radiomic data, the miRNA blood test, and other clinical characteristics and could be easily used by patients and physicians to more accurately predict IPMN pathology, and 3) evaluate the relationship between radiomic features and biological processes that underlie IPMN tumor development and/or progression.